UC Davis Conte Center: Neuroimmune Mechanisms of Psychiatric Disorders

PROJECT SUMMARY - OVERALL
Psychiatric illnesses, including schizophrenia, affect a significant proportion of the population, yet current
treatments are only partially effective for many individuals and, in the case of SZ, do little to address disabling
cognitive and negative symptoms. Thus, there is a pressing need to develop biomarkers to identify at-risk
individuals for early intervention and new molecular pathways to target for development of novel therapies. An
increasingly compelling pathway associated with SZ is immune dysregulation. This proposed renewal of the
UC Davis Conte Center brings together investigators with a unique combination and wide range of
complementary expertise to address a critical gap in knowledge related to the potential links between immune
dysregulation and psychiatric illness. During the previous funding period, we took a multi-pronged approach to
test our Center hypothesis that early activation of the maternal immune system alters brain development
in offspring leading to structural and functional changes in connectivity that are associated with the
emergence of psychopathology in adolescence and young adulthood. Four important findings emerged
from those studies that serve as the premise for this renewal application. First, we discovered two factors in the
mouse model that predict susceptibility and resilience of offspring to MIA, allowing us to study why MIA causes
aberrant outcomes in only a subset of pregnancies and how it can lead to diverse phenotypes in offspring.
Second, we found signatures of abnormal brain development in our male MIA NHP offspring as early as 6
months of age, indicating that the early postnatal period is critical for understanding the impact of MIA on brain
development. Third, combined results from NHP and mouse models point to cortico-striatal circuitry as central
to behavioral outcomes in MIA offspring. Finally, convergence between MIA NHP imaging findings and recent
onset SZ support the clinical relevance of the MIA models. In this renewal, we will continue to test our original
Center hypothesis across species (mouse and NHP MIA models and humans with SZ), through three specific
aims: (i) Identify immune signaling pathways in females before and during pregnancy that confer susceptibility
or resilience to distinct subsets of MIA-induced behavioral phenotypes in offspring, (ii) Determine the
contribution of cortico-striatal circuits to susceptibility, resilience and phenotypic heterogeneity in MIA mouse
and NHP offspring and in individuals with SZ, and (iii) Determine how sex contributes to susceptibility,
resilience and phenotypic heterogeneity in MIA offspring and individuals with SZ. Successful completion of
these Aims, which could only be accomplished in a highly integrated interdisciplinary Center as proposed, will
identify causal molecular pathways in specific neural circuits critical for guiding the development of
interventions optimized for the developmental age and sex of at-risk offspring following MIA. They will also
reveal new immune signaling pathways that can be targeted for the development of biomarkers to identify at-
risk pregnancies, and a new class of much-needed therapeutic interventions to prevent SZ and other NDDs.

Public health relevance
PROJECT NARRATIVE – OVERALL Despite strong links between maternal infection and neurodevelopmental disorders, little is known about why some pregnancies are susceptible, and others resilient, to this risk factor and why the susceptible pregnancies lead to a wide range of distinct disorders in humans. Using a newly discovered approach that predicts outcomes, we will measure changes in maternal immunity and cortico-striatal circuits in five highly interactive projects using mouse and NHP models of MIA and individuals with schizophrenia, to determine factors in the mother and offspring that contribute to susceptibility and resilience to different phenotypic outcomes. If successful, our results will identify causal molecular pathways in specific neural circuits critical for developing interventions optimized for the developmental age and sex of at-risk offspring following MIA, as well as biomarkers to predict pregnancies most at risk and approaches to prevent behavioral aberrations in offspring.